Viral and Respiratory Pathogens Research Center

The Viral and Respiratory Pathogens Research Center supports translational and clinical research focused on the development and optimization of control measures for viral and bacterial respiratory pathogens.